Neutrophils play a pivotal role in vascular aging

Project Summary/Abstract
Socioeconomic status and psychological stressors are known to contribute significantly to
vascular aging, a process of gradual deterioration of blood vessel structure and function,
leading to the development of cardiovascular diseases (CVD). Chronic inflammation is
believed to mediate vascular aging. We discovered that mice lacking neutrophil elastase (NE),
a serine protease released by neutrophils, significantly reverse aging-related arterial stiffness,
a hallmark of vascular aging. Our observations suggest that neutrophils and NE are pivotal in
aging-related vascular stiffening. Our parent grant, funded by NHLBI, investigates the
molecular mechanism by which NE interacts with the vascular cells, contributing to
inflammation, fibrosis, and calcification in the arterials. However, whether stress-related
vascular aging is mediated by neutrophil activation and subsequent vascular inflammatory
damage is unknown. We hypothesize that social stress can activate the sympathetic nerve
system (SNS) and release catecholamines from the sympathetic nerve terminus.
Catecholamines stimulate the cAMP signaling and activate the hormone-sensitive lipase
(HSL) pathway, leading to lipolysis and free fatty acid (FFA) formation. FFAs increase G-CSF
expression, stimulating neutrophil production and mobilization from BM to blood circulation,
increasing neutrophil-vascular cell interaction and inflammatory injury, and accelerating
vascular aging and the development of cardiovascular diseases. Our NE knockout (NEKO)
mice provide a unique and valuable tool to evaluate the potential link between neutrophil
activation and social stress-related acceleration of vascular aging. Here, we propose to
examine and compare social isolation-induced stress responses and signaling in bone
marrow (BM), neutrophil activation, and vascular stiffening with NEKO mice and wild-type
littermates. This supplement proposal integrates well with and within the scope of the parent
project, connecting neutrophil activation and vascular aging. Successful completion of the
project provides a solid foundation for a new RO1 proposal for the candidate and new insight
into the cellular and molecular mechanisms of social stress-related vascular aging and
cardiovascular diseases.

Public health relevance
Project Narrative This project is designed to understand how stress activates neutrophils and to evaluate if activated neutrophils are involved in stress-related acceleration of vascular aging. Completing this supplemental proposal will support neutrophils’ role in social stress-accelerated vascular aging and provide new insight in developing strategies for preventing and treating aging-related cardiovascular diseases.